Oncopathology Training Program

PROJECT SUMMARY
This is a new application for a Ruth L. Kirschstein National Research Service Award Institutional Research
Training Grant (T32) to train post-doctoral trainees in the field of oncopathology, defined broadly as research
that seeks to improve our understanding of cancer pathogenesis and pathobiology, and in doing so provide the
basis for the development of new approaches that improve cancer diagnosis, prognostication, and treatment.
The overall goal of the Oncopathology Training Program (OTP) is to provide research training opportunities
across the full spectrum of oncopathology research, from basic study of cancer pathogenesis using the tools of
cell and molecular biology, genomics, proteomics, animal modeling, and bioinformatics, to translational
research that involves the development and deployment of biomarker tests and the use of digital and
computational pathology, approaches that are increasingly important in cancer research. The training program
is designed to benefit the research career development of M.D. and M.D./Ph.D. trainees subsequent to their
training in clinical and/or anatomic pathology, and Ph.D. trainees with educational backgrounds in
computational fields interested in the emerging area of computational pathology. Support is requested for 4
postdoctoral trainees in years 1-2, and 5 trainees in years 3-5. The training program includes structured
elements such as individual development plans, mentored research experiences, and customizable didactic
training opportunities as well as workshops in grant writing, manuscript composition, and lab management.
Each trainee will have Postdoctoral Advisory Committee comprised of the Program Director, primary research
mentor, and one or more senior cancer researchers with relevant expertise that will review trainee progress,
provide advice and constructive criticism, and serve as a review committee for external fellowship proposals.
The OTP faculty includes 24 highly accomplished investigators, with extensive mentoring track records and
substantial extramural grant support, who constitute a highly collaborative mentoring community whose
expertise span a wide-range of multidisciplinary, oncopathology-relevant areas, including animal modeling of
cancer, cancer immunology, cancer genomics, computational pathology and tissue imaging, cancer
diagnostics, and translational cancer informatics. The OTP will also take advantage of the extensive
complement of scientific and educational resources that are available at Brigham and Women’s Hospital
(BWH), Harvard Medical School (HMS). and Dana Farber Cancer Institute (DFCI), including the NCI-funded
Dana-Farber/Harvard Cancer Center.

Public health relevance
PROJECT NARRATIVE Cancer researchers grounded in the field of pathology are critically needed if basic insights into the pathobiology of cancer are to translate into improved patient treatment and better patient outcomes. To address this need, the Oncopathology Training Program at Brigham and Women’s Hospital will provide physicians trained in the field of pathology with the comprehensive mentored research and didactic training experience that is needed to prepare them for careers as cancer investigators. We seek to train future leaders in pathology who not only provide new insights into the cause of cancer, but also bring innovative approaches to the diagnosis and treatment of cancer to the clinic, to the benefit of cancer patients and their families.